Biomaterial Scaffolds for In Vivo CAR T Cell Manufacture

PROJECT SUMMARY
CAR-T cell therapy has revolutionized the treatment of liquid tumors, including leukemia and lymphoma, and
hold enormous promise for treatment of solid cancers as well. However, despite their unprecedented clinical
success, widespread utilization of this therapy is hampered by the lengthy and labor-intensive manufacturing
procedures. CAR-T cell manufacturing is both laborious and time-consuming, results in very high costs of therapy
(~$500,000). The long manufacturing time creates delays of weeks or months to infuse CAR-T cells to patients
with rapidly progressing disease. Extensive ex vivo cell manipulation creates cell products with heterogeneous
composition and terminal differentiation that limit CAR-T cell engraftment and persistence. Effort to overcome
these limitations have focused on closed and automatic manufacturing devices to contain the labor needed to
manufacture CAR-T cells ex vivo, and allogeneic off-the-shelf CAR-T cells have been proposed to overcome the
need of CAR-T cell manufacturing for each single patient. These technologies are promising, but reducing the
time, costs and regulatory burden of manufacturing or eliminating ex vivo procedures entirely remains a critical
unmet need. In vivo generation of autologous CAR-T cells would eliminate the ex vivo procedures, prevent the
terminal differentiation of ex vivo expanded CAR-T cells and ensure the potency and longevity of autologous T
cells as compared to allogeneic CAR-T cell products that are extensively manipulated to prevent rejection and
graft-versus-host disease. This proposal outlines the first steps in a highly innovative high-risk/high-reward effort
to develop bioinstructive biomaterials scaffolds that generate CAR-T cells entirely within the patient and produce
CAR-T cells with improved efficacy and persistence. Our endeavor is built on significant published and prelimi-
nary data demonstrating that our biomaterial scaffolds already efficiently activate and mediate CAR-T cell trans-
duction in vitro and efficiently recruit and release CAR-T cells in vivo and reduce CAR-T manufacturing times
from weeks to a single day. We propose that biocompatible alginate biomaterial scaffolds can be modified to
encapsulate T cell-attracting chemokines to recruit T cells to the scaffold. After recruitment, the biomaterial scaf-
folds will provide αCD3/CD28 signaling to activate the T cells. After activation, T cell-specific viral particles either
already present in the biomaterial or administered to the biomaterial as a separate step will transduce the T cells,
generating tumor-specific CAR-T cells in situ in manner compatible with irradiative lymphodepletion. Finally,
interleukin signaling in the scaffold will expand and promote release of formed CAR-T cells for systemic efficacy.
This approach could have enormous clinical impact by significantly reducing therapy costs and dramatically
expanding the patient population benefiting from CAR-T-cell therapy. We expect that these studies will provide
a foundational technology for CAR-T cells manufacturing and promote widespread patient access. In addition to
the clear application in cancer, however, this rational, materials-based approach for cellular manufacturing could
be adopted to program therapeutic lymphocytes in solid tumors and for other diseases.

Public health relevance
RELEVANCE TO PUBLIC HEALTH CAR-T cell therapy reprograms a patient’s own immune cells to identify and destroy tumors with precision, trans- lating to revolutionary new treatment paradigm for certain blood cancers. Unfortunately, CAR-T cell therapy is enormously expensive, (~$500,000 per dose) and has a slow manufacturing process and enormous regulatory hurdles for facilities that manufacture CAR-T cells. We will develop a technology to manufacture CAR-T cells within a patient's own body to dramatically cut costs and increase patient access.